A Scientific Retreat to Address Ethical Challenges in Data and Sample Sharing to Advance Neurodegenerative Research

Project Summary
New and emerging policies, including the NIH Data Management & Sharing Policy (NIH DMS), establish
expectations that investigators share or make available data or study samples. Investigators understand and
support the value of data sharing in advancing significant findings and therapeutic goals.1 Yet, investigators
and participants report ethical concerns associated with data and sample sharing practices in
neurodegenerative research. Investigators currently lack guidance on emerging ethical challenges inherent
to data and sample sharing. The lack of guidance and need for “best practice” standards call for innovative
approaches. The objective of the proposed Conference Grant is to support a one and a half-day retreat aimed
at generating solutions to ethical challenges that could be barriers to data and sample sharing practices within
neurodegenerative disease research. Interdisciplinary experts, with diverse professional backgrounds, will
gather annually. Each year, the organizing committee will identify an ethical issue that will be the focus of the
retreat for that year. We will then identify speakers and attendees who are positioned to make meaningful
contributions aimed at generating solutions. The retreat will consist of a combination of presentations aimed
at exploring the state-of-the-science regarding the focused topic and moderated and structured discussions.
The aim of the yearly retreat will be to generate scalable and implementable solutions that will advance ethical
data and sample sharing practices.

Public health relevance
Project Narrative The proposed Retreat, A Scientific Retreat to Address Ethical Challenges in Data and Sample Sharing to Advance Neurodegenerative Research, aims to generate practical and scalable solutions to ethical challenges that could otherwise impede data and sample sharing. The proposed Retreat will bring together diverse interdisciplinary experts yearly. Each year the Retreat will target a specific ethical issue over a 1.5- days meeting that develops collaborations and create plans for developing and implementing ethical approaches to data and sample sharing.